Structurally and biochemically defining divergent actin and its non-canonical regulators in Giardia

PROJECT SUMMARY
Infection by the unicellular parasite Giardia lamblia leads to intestinal distress and can cause severe
malnutrition in children who remain untreated. Giardia infects over 300 million people annually, with 20% of those
cases being resistant to front-line treatment. Giardia attaches to the intestinal epithelium of its hosts with two
cellular structures: the ventral disk and the ventrolateral flange. Attachment research over the past fifty years
has focused on the suction-cup like ventral disk, whereas the lamellipodium-like ventrolateral flange remains
biochemically and structurally uncharacterized. Published work and our preliminary data indicate that the
cytoskeletal protein actin plays a central role in the ventrolateral flange. Giardia has the most divergent actin
sequence identified in eukaryotes and lacks all of the canonical, eukaryotic actin-binding proteins, yet actin is
involved in several core cellular processes in Giardia, including cytokinesis and cell morphogenesis. Together
this suggests that the mechanisms by which Giardia builds actin-based cellular structures differ significantly from
other eukaryotes and that Giardia likely contains non-canonical regulators and novel actin-binding proteins that
modulate the actin cytoskeleton. This proposal describes approaches to characterize both actin (Aim 1) and the
flange (Aim 2) from Giardia using cryo-electron microscopy and super-resolution imaging. This work will define
the molecular underpinnings of the flange ultrastructure (Aim 2) and reveal the conserved and divergent
mechanisms of actin assembly, dynamics, and regulation in Giardia (Aim 1). Identifying functional properties that
distinguish the actin cytoskeleton of Giardia from its vertebrate homolog will provide opportunities for new drugs
that specifically target the parasite without harming the host. This work will also generate fundamental insights
into core actin properties.
This interdisciplinary research project is an exceptional postdoctoral training opportunity, leveraging
questions that sit at the nexus of several scientific fields and the resources available at the University of
Washington into an impactful research strategy and training plan. The PI will work jointly with two faculty mentors:
Dr. Justin Kollman, an expert in cryo-electron microscopy and divergent actins; and Dr. Alex Paredez, a leader
in research on Giardia who has developed many of the tools used to study actin in the parasite. In addition, the
PI has assembled a team of collaborators and mentors at the University and around the country. The University
will provide extensive training in the responsible conduct of research, professional skills, and teaching
pedagogies. Though the execution of the research strategy and training plan, the PI will gain technical expertise
in cryo-electron microscopy and super-resolution microscopy as well as the key career skills necessary to launch
an academic research laboratory. Together, this research and training will prepare the PI to conduct studies
bridging the resolution gap between individual proteins and the cell-level interactions of hosts and pathogens.

Public health relevance
PROJECT NARRATIVE The unicellular parasite Giardia infests aquatic environments throughout the world, infecting up to 30% of the population in countries with poor water sanitation and over 300 million people worldwide. Giardia uses the cytoskeletal protein actin to attach to the intestine, but how actin from Giardia functions at the molecular level and how it helps establish and maintain cellular attachment remains unknown. Here, I propose to study actin from Giardia at the molecular and cellular level to define targets for treatments to prevent parasite attachment in the intestine and to better understand unifying actin properties.